CLINICAL INVESTIGATION SECTION

"The Clinical Investigation Section of the NMOB is charged with maintaining vigorous clinical research activities and with sustaining educational programs for fellows, nurses, pharmacy, and other clinical staff."